The role of Staphylococcus aureus aggregate formation in establishing biofilms in chronic orthopaedic periprosthetic joint infection

Abstract No change from original proposal.

Public health relevance
Project Narrative No change from original proposal.